The relationship between language and executive function in DLD and FXS over time

PROJECT SUMMARY/ABSTRACT
Language impairments in children have a persistent, lifelong impact on social communication, academic
performance, and adaptive behaviors. Two clinical groups particularly impacted by language impairments
include developmental language disorder (DLD) and fragile X syndrome (FXS). DLD affects 7-13% of school-
age children, and is characterized by pervasive impairments in the grammatical system in the absence of an
intellectual disability. Fragile X is the most common inherited form of intellectual disability and males with FXS
have significant language impairments. Notably, there is a significant overlap in the language phenotype
between DLD and FXS, in terms of grammatical production. This is striking given the difference in general
cognitive abilities. Importantly, nothing is known regarding areas of overlap and distinction in grammatical
comprehension between the two disorders. Additionally, although these two clinical groups have very different
cognitive profiles in terms of IQ, there are overlaps in other aspects of cognition, namely executive function.
This is particularly interesting, given evidence of a relationship between executive function and language skills
during typical development as well as in children with DLD, however, this work is nonexistent in FXS.
Comparative studies between disorders with known (FXS) and unknown (DLD) etiology have the potential to
inform both theory and clinical practice. Thus, the proposed study has three specific aims designed to
systematically investigate areas of overlap and distinction in terms of language with a focus on grammatical
production and comprehension and the association with executive function in children with DLD and FXS in a
developmental framework. Through careful investigations we will be able to determine the developmental
trajectories of grammatical comprehension and production in addition to EF skills in DLD, FXS, and a language
matched group of children with typical development. We will recruit children with DLD (n = 40), children with
FXS (n = 40), and children with typical development (n = 60). Children will be matched on clause length to
ensure similar language abilities. The proposed study will include a combination of standardized assessments,
language samples, experimental tasks, and parent report measures taken at two time points in order to track
growth and change during this critical period for grammatical development. The proposed study will yield key
information regarding children's comprehension of grammar, change over time, best assessment methods, and
critical information on the relationships between executive function and grammatical development. The data
collected in this study will be used to inform treatment studies designed to maximize both the effectiveness and
efficacy of language learning in DLD and FXS in targeted intervention studies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it contributes to a program of research focused on significantly improving the communication abilities of children with language impairments, including children with fragile X syndrome and children with developmental language disorder (DLD). The proposed study will track language production and comprehension over time in school age children, considering the unique impact of one aspect of cognition (executive function). Given the prevalence of DLD (7-13% of school age children), and the significant overlap in the language phenotype between fragile X and DLD, this project addresses the NIDCD's mission to improve the lives of individuals with communication disorders.